Role of palmitoylation in regulating the epithelial sodium channel (ENAC)

Abstract: Epithelial Na+ channels (ENaCs) play a major role in controlling extracellular fluid volume by facilitating
Na+ absorption across transporting epithelial tissues, such as the kidney and distal colon. In the distal nephron,
K+ secretion also depends on ENaC-induced apical membrane depolarization. ENaCs are heterotrimeric
channels composed of homologous ,  and  subunits, each regulated by various transcriptional and post-
translational mechanisms. Previous studies using heterologous expression systems identified cys-palmitoylation
of ENaC  and  subunits as a major regulator of channel activity, and two key sites of palmitoylation in -ENaC’s
N-terminus (C33,C41) are required for normal channel function in vivo. CRISPR/Cas9 was used to generate
mice lacking these palmitoylation sites (C33A,C41A, “No-P” mice; No Palmitoylation site). We found that ENaC
activity in the aldosterone-sensitive distal nephron (ASDN) is significantly reduced, compared to littermate
controls. Studies proposed in Aim 1 will assess ENaC-dependent renal Na+ and K+ transport in the ASDN of
control versus No-P mice at baseline, and in response to dietary salt challenges. ENaC-mediated Na+ absorption
in the distal colon will be assessed by short-circuit current (ISC). Blood and urine analyses will provide novel
information regarding the effects of ENaC palmitoylation on electrolyte homeostasis. Phosphatidylinositol 4,5
bis-phosphate (PIP2) is a well-known ENaC activator, and key -subunit palmitoylation sites reside near identified
(PIP2) binding sites. Studies proposed in Aim 2 will examine whether palmitoylation facilitates PIP2 binding by
promoting an interaction between the N-terminus and the plasma membrane. These proposed studies will
provide novel in vivo insights into the functional importance of ENaC palmitoylation. Completion of this project
will equip the applicant with the necessary knowledge and skills to investigate mechanisms of epithelial transport
and renal physiology in future endeavors.

Public health relevance
PROJECT NARRATIVE: This proposal will address an important gap in our current knowledge about the regulation of epithelial sodium channels (ENaCs), which play a vital role in controlling extracellular fluid volume and blood pressure. We will generate valuable new insights into how ENaCs can be regulated in vivo by a process known as cys- palmitoylation, and how this process affects electrolyte handling in both the kidney and the colon. Our findings will contribute significantly to the advancement of the field of epithelial transport physiology by characterizing this previously unexplored aspect of ENaC regulation at the whole-organism, tissue, and molecular levels.